FOLLOWUP OF HEALTH AND NUTRITION EXAMINATION SURVEY I

The purpose of this project is to design and complete a followup of persons examined in the HANES I to study how factors previously measured relate to the health conditions that have developed since the survey. The three major areas for prediction of outcome are 1) nutrition 2) risk factors for chronic disease and 3) health care utilization. The survey will have a household interview including self-reporting of health conditions, utilization of health services and behavioral and social status plus some physical measurements as blood pressure, height, and weight. The field work for the NHANES I Epidemiologic Followup was completed in 1984 and the final data tapes have become available to the cooperating units. NIA/EDB staff are involved in analyses in the areas of hypertension, disability, cognitive functioning, osteoarthritis, hearing, sleep complaints, height/weight, and other subjects. A major area of investigation is nutrition and dietary behavior. The EDB Program is involved in publishing a book which will summarize findings from the NHANES I Epidemiologic Followup Survey. Continued Followup of the Elderly 1986 is underway. The first half of the pretest of the telephone interview is completed. The continued followup telephone interviews will be completed in fiscal year 1986. The response rate continues to be very high.